Supporting Undergraduate Research Experiences in Environmental Health (SURE-EH)

The University of Washington (UW) is a world-class research institution that holds diversity as a
core value. As a leader in environmental health science research, the UW is well-positioned to
assist the National Institute of the Environmental Health Sciences (NIEHS) with its strategic goal
to increase the diversity of the environmental health science research workforce. We propose to
continue our highly successful undergraduate training program – Supporting Undergraduate
Research Experiences in Environmental Health (SURE-EH) – specifically geared to this
strategic goal. SURE-EH provides environmental health science research experiences and
educational opportunities to at least four traditionally underrepresented undergraduate students
per year from across the UW. Participants are typically selected at the end of their sophomore
year and remain in the program for two years, including two summers. They conduct
environmental health science-related research in one of the wide range of disciplines
encouraged by NIEHS’ Strategic Plan. SURE-EH facilitates academic opportunities to
complement the research experience, including course recommendations, seminars,
workshops, and research symposia. These educational opportunities enhance the breadth and
depth of SURE-EH participants’ environmental health science training. SURE-EH trainees will
learn responsible conduct of research by participating in the summer Biomedical Research
Integrity program and will be directed to courses where they can learn about the ethical conduct
of science. These educational opportunities complement the research experience, and in
combination with the outstanding and broad-based environmental health science expertise of
UW faculty, ensure the SURE-EH participants are well-positioned to become future leaders in
the field of environmental health sciences.

Public health relevance
NIEHS recognizes that promoting healthier lives involves discovering how the environment affects people. It is essential that the workers making these discoveries represent everyone, including individuals who are traditionally underrepresented. The SURE-EH program will provide research experience and educational opportunities in the environmental health sciences to University of Washington undergraduate students from traditionally underrepresented backgrounds.